Animal, Biochemical/Molecular and Morphology Core

Project Summary- Core B
The overall theme of this program is to determine the mechanisms underlying sympathetic nerve activation
caused by chronic intermittent hypoxia (CIH), a major manifestation of sleep apnea. All projects require
exposing either intact, un-sedated rodents or cell cultures to an IH paradigm mimicking the blood O2 saturation
profiles encountered during sleep apnea. Use of the same IH paradigm across all projects is essential as it
allows longitudinal integration of results. This goal will be best accomplished by a centralized scientific facility.
All projects utilize genetically engineered mice. Scientific Core provides centralized facilities with dedicated
scientific personnel overseeing the genotyping and maintaining breeding colonies, which otherwise is cost
prohibitive for individual projects. All projects in this program propose a variety of biochemical and molecular
biology assays as well as morphology studies that are common amongst projects. Performing these assays
under the Scientific Core is economical and allows use of the common reagents; antibodies etc. and more
importantly provide quality control. Thus, the overall goal of the Scientific Core is to support centralized
scientific services to all four projects proposed. The following are the SPECIFIC AIMS of the Scientific Core.
AIM 1: Provide centralized facility for exposure of animals and cell cultures to intermittent hypoxia. AIM 2:
Provides biochemical and molecular biological assays. AIM 3: Provide morphology assays. AIM 4:
Provide help with statistical analysis of the data. The Scientific Core will be directed by Dr. Y-J- Peng, an
experienced cardio-respiratory physiologist. Key Personnel include: Drs. J. Nanduri (expertise- biochemical
and molecular biology approaches, A.J. Garcia (expertise- generating mice with targeted disruption of genes)
and D. Nicolae (expertise- statistical and computational modeling and analyses). Key personnel will be
assisted by Staff Members including Dr. S.A. Khan, Ms. N. Wang and Mr. B. Wang. The Scientific Core is
situated at the Institute for Integrative Physiology (IIP) of the University of Chicago, where most of the
proposed research will be conducted.